Total Synthesis of Peloruside A

[unreadable] DESCRIPTION (provided by applicant): Peloruside A is a recently isolated, cytotoxic, macrolide harvested from Mycale marine sponges off the coast of New Zealand. This compound has been shown to be cytotoxic to a variety of cancerous cell lines in vitro and warrants further evaluation as a potential pharmacological agent. Unfortunately, supplies of this biologically active compound are limited and full testing awaits total synthetic efforts. This proposal seeks to provide a synthetic route to peloruside A that is expeditious, convergent and amenable to scale-up. In addition, this proposal looks to investigate two methods of organic synthesis; asymmetric glycolate aldol condensations and a novel, titanocene-promoted Reformatsky addition. [unreadable] [unreadable]